NNLM Region 6 Regional Medical Library

The Administrative Core focuses on the following four aims: governance, membership, collaboration, and emergency preparedness. The RML will prioritize a cooperative and collaborative governance model that ensures education, funding, and engagement activities will be responsive to the evolving health information needs of the Region, United States, and NNLM. Staffing the RML will include a director, associate director, five experienced librarians, and a communications and finance coordinator. Governance of the RML will include seven State Stakeholder Advisory Groups consisting of a broad group of professionals with expertise in a range of focus areas that align with NNLM’s target audiences, goals, and, priorities. These Advisory Groups will establish a bidirectional communication channel within each state and create state action plans to guide programming and services. An expanded Partner Outreach Program will establish a “field force” of trusted NNLM ambassadors within each state to provide greater exposure to NLM and NNLM products and services. This community-led model will expand NNLM’s presence in the many rural and urban areas spread out across Region 6. Both the State Stakeholder Advisory Groups and Partner Outreach participants will contribute to membership promotion, recruitment, and engagement. Region 6 will utilize direct outreach, targeted mailings, membership kits, and membership campaigns to recruit and engage Network members. Staff will also work cooperatively with NLM’s Office of Engagement and Training (OET) and other RMLs, Offices, and Centers to implement best practices regarding membership recruitment and engagement. This cooperation will extend beyond membership into all facets of NNLM work. Region 6 staff will actively participate on NNLM Working Groups and engage with coordinators across RMLs to identify opportunities to develop national programming that can be delivered regionally, and vice versa. The Network Coordinator will oversee the RML’s Emergency Preparedness and Response activities, including the coordination of state liaisons and e-newsletter development. The Associate Director will work with OET and other RMLs to establish protocols to ensure continuity of services in the event that an emergency disrupts services.